Genetic and environmental factors affecting alternative lengthening of telomeres

Telomeres protect chromosome ends in eukaryotes. In the absence of telomerase, telomeres shorten, which
eventually leads to senescence. A minority of cells, however, can escape senescence and stabilize telomeres
by a recombination process called Alternative Lengthening of Telomeres (ALT). ALT is responsible for telomere
maintenance in ~15% of cancers, but it also contributes to stabilization of telomeres in aging or stem cells. Thus,
understanding the ALT mechanism is important to identify factors that can influence whether and how it occurs.
It is also well known that exposure to various environmental stressors and air toxins influence all aspects of
telomere biology and promote telomere-related diseases, including various types of cancer. However, the effects
of environmental factors on ALT and telomere dynamics are difficult to study, owing to the absence of experi-
mental systems to identify and follow the critical steps responsible for ALT establishment in human cells at the
molecular level. A key gap in the study of ALT has been, until recently, the lack of quantitative assays. The goal
of this research is to unravel the mechanisms of ALT by identifying genetic, structural, and environmental factors
affecting ALT. This research takes advantage of a powerful system in yeast, Saccharomyces cerevisiae, where
ALT was originally discovered and where ALT can be followed from the beginning of telomere erosion through
formation of survivor cells. This research will employ a unique combination of methods that were recently devel-
oped by the applicants that enabled a quantitative study of ALT. This research, so far, has yielded three firsts in
the field: (i) a population genetics-based assay that determined the frequency of ALT, (ii) ultra-long sequencing
described the detailed structure of individual chromosome ends in ALT survivors, and (iii) a combination of com-
putational modeling, Southern blot analysis and PacBio sequencing uncovered “molecular milestones” repre-
senting different steps of ALT in large populations of yeast cells. Using these new approaches, this research will
determine the effects of genetic, chromosome-structural and environmental factors during the steps of ALT,
including: (i) the formation of ALT precursor cell populations initiated by eroded chromosome ends; (ii) the de-
velopment of ALT survivors taking place in such populations; (iii) the frequency of ALT outcomes, and (iv) the
molecular structure of chromosome ends in ALT survivors. This research will test the effect of environmental
stressors on ALT, including oxidative damage from paraquat and the effect of cadmium, a ubiquitous environ-
mental pollutant and a type I carcinogen. This will provide insight into molecular effects of environmental factors
as well as illuminate new molecular mechanisms of ALT formation, potentially uncovering opportunities for med-
ical interventions. Furthermore, this research will establish a robust system to evaluate the influence of other
environmental contaminants on ALT, and to utilize telomere erosion and ALT formation as a new type of biosen-
sor to assess the effects of various genetic changes and environmental assaults on genetic stability. Overall,
this study of ALT in yeast is expected to serve as a roadmap to perform quantitative studies of ALT in humans.

Public health relevance
Alternative lengthening of telomeres (ALT) is responsible for telomere maintenance in some cancers and can be activated in other cancers by anti-telomerase treatments. The proposed research will unravel the mechanism of ALT through identification and quantitative characterization of genetic, structural, and environmental factors af- fecting ALT establishment in yeast, and it will serve as a roadmap to perform quantitative studies of ALT in humans.